ICREATE: Increasing Capacity for Injury Research in Eastern Europe

Project Summary/Abstract
The global injury burden is disproportionately concentrated in low and middle income countries. This
project, named ICREATE: Injury Capacity in Research in EAsTern Europe, expands on five successful years
of building injury research and education capacity in the countries of Armenia, Georgia, and Moldova. These
countries are strategic global priorities due to their political and economic ties to the Middle East, Russia,
and Europe. Through a European Union TEMPUS grant, our partner institutions established MPH programs
in 2010, but at that time no programs had injury or violence course content or research. After our first cycle
of funding, all MPH programs, as well as one new undergraduate program in Moldova, have injury content in
the core curricula. We have built data capacity through the establishment of an 8-hospital emergency
department trauma registry and an NIH-funded prospective brain injury registry; these databases have been
used for student projects, and trainee publications and presentations. In our first cycle, we trained 40 MPH
students, 9 PhD students, mentored 43 experiential learning projects, and published 13 papers.
In the next funding cycle, we propose the following aims: train a critical mass of researchers from
Armenia, Georgia, and Moldova to conduct innovative research; facilitate the transition of trainees to
positions of leadership; develop our partner institutions as sustainable centers of excellence in injury
research and education; and, engage partners to translate research into effective prevention and treatment
programs. Our original topic areas of focus on road traffic injury, interpersonal violence, and acute care will
be expanded to include alcohol use, and we will expand our methodologic focus on data and analytic
capacity to include implementation science. Our program will prioritize MPH and PhD training to build
research and leadership skills focused on injury and violence prevention. Through a credit-sharing
agreement, trainees will be able to study at multiple institutions during their degree program. Now that
partner institutions have implemented injury curricula, PhD degree training will shift from the University of
Iowa to partner countries. Our Injury Prevention Summer Course, previously hosted at the University of
Babes-Bolyai, will now circulate between partner institutions, taught by trainee alumni appointed as faculty.
Partner countries will continue to host annual research symposia to highlight trainee research and to
promote the field of injury and violence research. We plan for these activities to build sustainable research
and education capacity that will lead to reductions in the burden of traumatic injuries and violence.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Project Narrative This project, ICREATE (Injury Capacity in Research in EAsTern Europe), expands successful capacity building in injury and violence research and education in Armenia, Georgia, and Moldova. Training is led by a strong collaborative team at the University of Iowa in the US and the University of Babes-Bolyai in Romania. This partnership has implemented injury core curricula in public health degree programs and established research in our focus areas of road traffic injury, violence against women and children, and will improve acute injury treatment, and we expand to examine alcohol as a risk for injury and implementation science. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page